Administrative Core

The Administrative Core provides centralized coordination of all Center resources and support services, including the structured meetings for the Internal Advisory Board and meetings with Center faculty to assess the progress of the Center Projects, pilot studies and educational activities. In addition, annual meetings with our External Advisory Board (consisting of experts in the field outside our institution), to provide feedback on the progress of the Center and recommendations for future initiatives, will be scheduled through this Core. The Aims of the Administrative Core include 1) Establish an administrative structure to assure that there is a clear line of authority to make decisions concerning budgets and allocation of resources and staffing. 2) Establish an Internal Advisory Board consisting of the Directors of each of the Cores (Administrative, Research, Pilot Project, and Training and Education), along with Dr. Herbert Kleber, who will serve as our senior advisor. 3) Provide crucial administrative functions to ensure that the Center operates in an efficient and cost-effective manner. These include: a) centralized personnel activities, b) centralized financial activities, c) maintenance of research records, and d) liaison activities across institutions. 4) Provide the technical support to develop and maintain a dedicated Center website, upgrade the webhosting server, and use social media to enhance outreach for recruitment and dissemination of the Center's key research findings. The technical staff will ensure that Studytrax for the clinical Projects and pilot studies is swiftly implemented and running efficiently. 5) Establish an External Advisory Board, consisting of experts in the field, who are charged with objectively evaluating whether the Center is meeting its objectives, whether the productivity is adequate, and whether the proposed educational initiatives are being achieved. 6) Dr. Levin will liaise with the Department of Psychiatry administration, who has agreed to provide the necessary space, ancillary services and salary support to allow the efficient conduct of the proposed research, educational, and training activities outlined in the other Cores, Projects, and Pilots of the proposed Center. The Aims of the Administrative Core are to provide the coordinating structure for all of the other Cores and Projects to ensure that the goals of all aspects of the Center are met and that there is cooperation and collaboration, both in carrying out the proposed work and facilitating communication for each of the Center components. The Administrative Core is designed to centralize various administrative tasks to ease the burden for each individual Project and Core, allowing the Project and Core Directors to focus their efforts on the overarching goal of this Center: developing pharmacotherapeutic strategies to treat cannabis and opioid use disorders.